Administrative Core

CAPES ADMINISTRATIVE (ADMIN) CORE: PROJECT SUMMARY/ABSTRACT
Significance: A strong, effective Administrative (Admin) Core is essential for maximizing the scientific and
public health significance of the Center for Accelerating Practices to End Suicide through Technology
Translation ( ). To do this, the Admin Core will provide the organizational framework, governance,
CAPES
resources, training, networking, and synergy that will assure projects and trainees supported by CAPES are
poised to accelerate suicide prevention in healthcare systems significantly.
Investigators: CAPES Admin Core Co-Leads (Boudreaux, Kiefe) are seasoned leaders of large trans-
disciplinary teams and have strong experience in Center management. They are complemented by Unit Leads
with extensive expertise in technology-related business and commercialization (Dunlap), scientific education and
development (Mick), dissemination and community engagement (Larkin), and ethics (Nebeker).
Innovation: The Admin Core is particularly innovative in its promotion of business development and digital
health technology ethics. These have infused each project from the earliest planning stages. With longitudinal
guidance throughout each project’s lifecycle, the Admin Core will position each to not only support the public
good through scientific advancements but also for rapid translation to commercial success in a way that is
sensitive to ethical concerns, e.g., respect for privacy and autonomy.
Approach: CAPES Admin Core will use a proven milestone-driven management approach to keep strong,
effective lines of communication; identify problems early; and effectively deploy and redirect resources to
promote success. It will create an infrastructure for awarding ~10 innovative Pilot Projects and will support a rich
and innovative educational program for trainees. The CAPES Stakeholder Panels, including Patient and Family,
Clinician, IT/IS, and National Influencers, will be built, expanded, and managed by the Admin Core to effectively
guide CAPES overarching direction as well as individual projects. Synergy will be generated through purposive
activities to create a synthesis that honors both our experts’ experience and Stakeholders’ perspectives. The
Admin Core will execute the multi-channel resource sharing plan that includes direct-to-community efforts, as
well as a sophisticated, multi-platform social media strategy. The Admin Core will partner with the Methods Core
to complete regular, rigorous evaluations of the Center’s progress, the results of which will inform adjustments.
Environment: UMass Medical School, other UMass campuses, Worcester Polytechnic Institute, and other
partnering organizations provide ample resources to support a highly effective Admin Core.
Impact: The Admin Core will exert its impact on science and public health by fostering a vibrant, synergy-
producing ecosystem to support Faculty and trainees so they can produce cutting-edge science and know-how
that accelerates adoption and implementation of suicide care technologies. Through fostering this accelerated
translation, CAPES will save lives and reduce suffering and costs associated with suicide.

Public health relevance
CAPES ADMINISTRATIVE (ADMIN) CORE: PROJECT NARRATIVE See Project Narrative in the Overall component.